Preclinical development of DMD exon 44 skipping using AAV.U7snRNA: a versatile tool that can help 6-12% of DMD patient

PROJECT SUMMARY/ABSTRACT
Duchenne Muscular Dystrophy (DMD) typically results from mutations in the DMD gene that disrupt the open
reading frame, resulting in no dystrophin protein production. In contrast, the milder Becker Muscular Dystrophy
(BMD) typically results from mutations that allow expression of a partially functional dystrophin protein. Current
therapeutic approaches in trials are directed toward expressing shorter, “micro-dystrophin” proteins, likely
ameliorating DMD into a BMD-like phenotype. An alternative approach is to use exon skipping. This strategy
uses antisense oligonucleotide sequences (AONs) to modulate pre-mRNA splicing of DMD transcripts to restore
the reading frame and to express a truncated but functional dystrophin. An alternative approach is to use a small
virus, such as Adeno-Associated Virus, containing a small promoter expressing the AON (also referred as
vectorized exon skipping [VES]), alleviating the need to reinject the AONs as they get degraded over time. Based
on our published studies in mice and our publicly presented data in infant Dup2 patients, VES for DMD exon 2
demonstrate a more robust exon skipping and protein expression than the alternative exon skipping approach
using AONs. Exon 44 is among the mutational hotspots of the DMD gene, and its skipping would benefit around
6-12% of DMD patients. Our long-term goal is to develop a vector that maximizes exon 44 skipping to provide
the best potential outcome for this patient subpopulation. Our central hypothesis is that VES will provide a robust
exon-skipping response, leading to therapies with significant efficacy. We have already generated promising
preclinical data for this program, but a new vector design is required for the next phase, especially if this vector
becomes commercially available. In Aim 1 (R61 phase, year 1), we will compare our current VES with a newly
designed one that will have manufacturing advantages compared to our current vector both in vitro and in vivo.
In Aim 2 (R61 phase, year 1-2), we will check if the designed vectors have splicing off-targets by RNA seq
analyses. In Aim 3 (R33 phase, years 2-3), we will test a minimal efficacious dose of our lead candidate to
generate data for a pre-Investigational New Drug (pre-IND). Our rationale for this project is that evaluation of
potential therapeutic vectors, assessing their efficiency and confirming absence of off-targets, measuring minimal
efficacious dosage, and early engagement with the FDA will lead to a streamlined path toward vector
development. The immediate impact of our work will be data to support our ongoing interaction with the FDA in
developing rapid VES personalized gene therapies.

Public health relevance
PROJECT NARRATIVE Duchenne Muscular Dystrophy (DMD)is a rare neuromuscular disease almost exclusively affecting boys caused by the absence of the protein dystrophin, normally expressed in the musculature and the nervous system, with severe and fatal results. This proposal is relevant to public health as it seeks to explore the benefit of therapy to restore dystrophin expression for patients that can be treated with exon 44 skipping, which represents 6-12% of DMD patients. This proposal aligns with the mission of NINDS to seek fundamental knowledge and development of pertinent therapeutic strategies to reduce the burden of neurological disease for all people.